ORAL ZIDOVUDINE IN HIV INFECTED PREGNANT WOMEN AND THEIR INFANTS

A phase III randomized, placebo-controlled multi-center trial to evaluate the efficacy, safety and tolerance of oral zidovudine in HIV-infected pregnant women and their infants.